The Value of High Quality Medical Care for Work-Associated Carpal Tunnel Syndrome

DESCRIPTION (provided by applicant): Carpal tunnel syndrome (CTS) commonly affects working-age adults, causes severe functional impairment, and leads to both medical and disability costs. Consequently, affected individuals must receive optimal medical care so that they can rapidly return to full, productive lives. Yet many studies have demonstrated that care in the U.S. is of suboptimal quality. For work-associated CTS, high quality medical care is likely to provide exceptional value to stakeholders within the healthcare system. Better care may improve patients' functional status and reduce wages lost during time off work. Improved functional status may also lower costs to employers by reducing disability payments and medical care costs. Workers' compensation policymakers, payors, and providers around the country appear to accept that quality care can produce value-yet few, if any, have implemented programs to monitor or improve quality. Deterrents include a lack of relevant quality measures, a misperception that limiting excessive use of medical care solves most quality problems, and a lack of early adopters from whom others can learn the whys and hows of quality improvement. In California, a few major policymakers, payors, and provider organizations are prepared to act-to become the early adopters from whom others can learn. This project seeks to measure quality of care for CTS, assess value to workers and payors, and lay the groundwork for ongoing quality assessment and improvement programs in workers' compensation settings nationally. To achieve these short and long-term objectives, this project has four specific aims: (1) to assess adherence to care processes recommended for work-associated CTS, (2) to examine the relationship between adherence to recommended care processes and outcomes for patients with CTS, (3) to examine the relationship between adherence to recommended care processes and the financial burden of CTS for workers' and payors, and (4) to disseminate findings to workers' compensation stakeholders and policymakers. This project will achieve these aims by studying 1,200 patients with workers' compensation claims for CTS who are treated by a major workers' compensation provider organization in Northern California. Quality will be assessed using the recently developed RAND/UCLA CTS Quality Measures. Surveys of patients at claim submission and 18 months later will provide information on symptoms, functional status, and lost wages. Costs to employers will be based on the costs of medical care plus disability payments. Established relationships with workers' compensation provider organizations, payors, and policymakers in California and other states will facilitate the dissemination of this work. The proposed research directly pertains to AHRQ's mission and goals, specifically: the health care system's ability to...deliver high-quality, high-value healthcare; and provid [ing] policymakers with the ability to assess the impact of system changes on...quality...[and] cost...

Public health relevance
PUBLIC HEALTH RELEVANCE: Ensuring that patients with work-associated carpal tunnel syndrome receive high quality medical care may not only improve the patients' symptoms and ability to function, it may also save both the patients and their employer's money. This project will examine the quality of care provided to patients with CTS, determine how much quality influences patients' symptoms and ability to function, and examine how quality affects costs to patients (lost wages due to time off work) and their employers (medical care costs and disability payments). PROJECT NARRATIVE Ensuring that patients with work-associated carpal tunnel syndrome receive high quality medical care may not only improve the patients' symptoms and ability to function, it may also save both the patients and their employers money. This project will examine the quality of care provided to patients with CTS, determine how much quality influences patients' symptoms and ability to function, and examine how quality affects costs to patients (lost wages due to time off work) and their employers (medical care costs and disability payments). __SpecificAimsTextDelimiter__ SPECIFIC AIMS In efforts to optimize the value produced by the U.S. healthcare system, commentators have often argued that better quality care will reduce costs. Much interest has focused on "the business for quality," which exists, according to an Institute of Medicine report, "...if the entity that invests in the intervention realizes a financial return on investment in a reasonable time frame...".1 A business case creates a natural incentive to improve quality. Yet researchers have found that a business case is often lacking for otherwise promising quality-improvement interventions.2 Implementation costs can be substantial, reducing the possibility of net savings.3 Fragmented healthcare systems can disrupt payoffs to the investing entities, which are often healthcare provider organizations. Time horizons may be overly long. Many costs of poor quality are borne by patients, such as when poor health status reduces their ability to function or increases their future need for medical care and its associated out-of-pocket costs. Lastly, the fact that patients change health insurance plans often reduces the chances that payors will experience savings.4, 5 The situation is much different in workers' compensation settings. Indeed, high quality medical care is likely to provide exceptional value to workers' compensation stakeholders. For occupational disorders, state laws generally require that employers cover the full cost of any necessary medical care, including future care, and provide disability benefits that cover up to about 67% of lost wages. If better care improves patients' health and functional status, and this, in turn, reduces time off work or the need for future care, costs to employers will decline. Patients will benefit through a decline in lost wages as well as improved health. Some workers' compensation policymakers, employers, payors, and providers around the country appear to accept that quality care can produce value-yet few, if any, have implemented programs to monitor or improve quality. Deterrents include a lack of relevant quality measures, a misperception that limiting excessive utilization of services solves most quality problems, and a lack of early adopters from whom others can learn the "whys" and "hows" of quality improvement. In California, a few major policymakers, payors, and provider organizations are prepared to act and to become the early adopters from whom others can learn. This project seeks to measure quality of care for carpal tunnel syndrome (CTS) in a large workers' compensation provider organization in California, assess value to workers and employers, and lay the groundwork for ongoing quality assessment and improvement programs in workers' compensation settings within California and elsewhere. CTS is one of the most problematical musculoskeletal disorders among workers because it is common, severe, and costly. Substantial variability in outcomes and care processes has been documented for patients with CTS, suggesting that care may be of uneven quality. Deficiencies in quality have been documented for many other conditions6 but, to date, quality of care has not been evaluated for CTS in a rigorous, systematic manner. To achieve its short and long-term objectives, this project has three aims: Aim One: To assess adherence to care processes recommended for CTS in a workers' compensation setting. Aim Two: To examine the relationship between adherence to recommended care processes and clinical outcomes for patients with CTS. Aim Three: To examine the relationship between adherence to recommended care processes and the financial burden of CTS for workers and employers.